Hormonal Control of Calcium Metabolism

Program Project "Hormonal Control of Calcium Metabolism" brings together a group of highly
productive investigators who have worked closely together for a number of years supported by the
project and other funded research grants. Tools of chemical molecular and cellular biology plus
available carefully designed genetically modified animals are used to evaluate the role of
parathyroid hormone in bone and renal cell biology. Several exciting medical translational
applications have already come from this work and the potential for several more is evident.
Project I (Gardella PI) Mechanisms of ligand binding and activation at the PTHR1 expands on earlier
work that probes molecular details of ligand/receptor activation including newly available small
molecule peptidomimetics as well as new chemical strategies to alter the pharmacokinetic and
therefore ultimately pharmacodynamic of PTH analogs. Important translational implications from this
work have been the discovery of a long-acting form of PTH for treatment of hypoparathyroidism soon
to be entering phase 1 clinical trials and development of peptide negative agonists that show
promise in animal models of controlling the multiple skeletal abnormalities seen in the hereditary
disorder Jansen's disease. Project II (Kronenberg PI) PTH actions on cells of the osteoblast
lineage builds on earlier progress with discovery of the first specific cellular target of PTH
action the SIK kinases. This discovery opens a new field of important basic science investigation
into the mode of action of PTH and has important translational implications in that the small
molecule kinase inhibitors already discovered might ultimately lead to an orally active agent
useful in the treatment of osteoporosis. Meantime these investigators continue to probe the effects
of PTH on cellular targets of PTH action in bone from earliest precursors to mature osteoblasts and
osteocytes. This work in addition to its fundamental interest could help with understanding how to
improve PTH action since it is known that its effect wanes after continuous use for 12 months or
less even though there are bone deficits remaining. Project III (Jueppner PI) renal regulation of
phosphate homeostasis and its effects on bone deals with several recent novel findings. The first
is importance of signal selectivity in PTH analogs in phosphate metabolism and bone cell maturation
and secondly, the implications of high bone mass seen with skeletal transgenic expression of the
Jansen's disease (JMC transgene) also studying a newly available specific inhibitor of NPT2A that
may prove to be useful in hereditary disorders of hyperphosphatemia and CKD. Project IV (Mannstadt
and Wein co-PI’s) The role of salt inducible kinases in renal PTH action builds on the recent
discovery of the importance of the SIK kinase family in PTH bone action the investigators having
demonstrated convincingly in preliminary work that SIK kinases are also critical to PTH actions on
the kidney.

Public health relevance
NARRATIVE Opportunity to close gaps in knowledge of molecular mechanisms of parathyroid hormone action (PTH) in bone and renal cell biology and mineral ion homeostasis with important potential translational applications in therapy of osteoporosis, hereditary skeletal and renal disorders, and chronic renal disease.